CORE--RESEARCH DEVELOPMENT

The Research Development Core (RDC) will provide the major training program for future clinical scholars in interventional strategies in age-related diseases/dysfunctions. the program will provide fellows and junior faculty the critical setting for developing expertise in experimental therapeutics (Griggs), biostatistics (Tanner), health service research (Phelps), and gerontological and geriatric science (Coleman/Hamill). These trainees will also have the opportunity to interact with a number of other postdoctoral fellowship programs in aging which exist in Rochester. Rochester has a long history of training academic leaders in science and medicine, and the mentorship program of the RDC will ensure guidance and improve the likelihood of trainees establishing independent careers.